EAST PALESTINE WORKSHOP- TWO DAY WORKSHOP

NCI support for the East Palestine Workshop. The purpose of the workshop is to explore potential research priorities to understand the short- and longterm health impacts of the Norfolk Southern Train Derailment. The workshop will be inclusive of the communities’ input and concerns.